Identifying Inflammatory Signals Facilitating Ectopic Krt5+ Cell Migration and their Function in the Alveoli

Abstract
Severe respiratory viral infections pose a significant risk and can result in debilitating lung diseases such as
acute respiratory distress syndrome and subsequent pulmonary fibrosis, which are prominent contributors to
global mortality. During severe respiratory viral injury, the lung initiates a distinct form of regeneration that is
independent of the functional regeneration facilitated by distal epithelial progenitors. This secondary "dysplastic"
mode of regeneration involves the activation of p63+ basal progenitor cells in the upper airways, followed by the
upregulation of Krt5, expansion, and migration into the alveoli, ultimately resulting in ectopic bronchiolization of
the alveolar epithelium. This dysplastic response is postulated to provide short-term benefits by restoring the
epithelial barrier; however, it ultimately results in a reduction of the total functional gas-exchanging surface area
of the lung. Ectopic Krt5+ cells are consistently observed in cases of both severe viral lung injury and pulmonary
fibrosis but have specifically been found to be strongly associated with fibrotic regions of the lung in cases of
pulmonary fibrosis. However, their specific involvement in fibrosis following viral injury and the underlying
mechanisms facilitating their ectopic migration from the proximal to distal airways remains poorly understood. In
my preliminary data, I observed a significant upregulation of canonical NF-κB transcription factors RelA, Nfkb1,
and c-Rel in ectopic Krt5+ cells. The NF-κB pathway is a well-known pro-inflammatory signaling pathway, and its
activation has been shown to promote epithelial-mesenchymal transition, migration, and proliferation. Aim 1 of
this proposal will assess whether canonical NF-κB signaling is necessary for ectopic Krt5+ cell expansion and
migration by utilizing a conditional deletion of IKKβ in p63+ progenitor cells. In vivo experiments will determine
the impact of IKKβ deletion on the total quantity of dysplastic Krt5+ epithelium following influenza injury through
immunofluorescent imaging and qPCR. Accompanying in vitro experiments will assess the specific migratory
and proliferative phenotypes associated with the loss of NF-κB signaling through in vitro gap closure and EdU
incorporation assays. Additional preliminary data revealed that ectopic Krt5+ cells highly express CTGF, a known
secreted pro-fibrotic growth factor, and are surrounded by more Collagen 1 compared to less-injured regions
following H1N1-induced lung injury. Aim 2 of this study will utilize a conditional deletion of CTGF and various
metrics, including immunofluorescence and hydroxyproline content, to determine whether CTGF is necessary
for the pro-fibrotic function of ectopic Krt5+ cells in vivo. Subsequently, we will elucidate the direct paracrine effect
of ectopic Krt5+ cells on fibroblast extracellular matrix deposition in vitro by culturing fibroblasts in conditioned
media from Krt5+ cells +/- CTGF and quantifying changes in matrix deposition. These experiments will investigate
the role of NF-κB signaling in dysplastic remodeling and the pro-fibrotic function of ectopic Krt5+ cells, thereby
providing insight into the underlying mechanisms governing their migration and fibrotic pathology.

Public health relevance
Project Narrative Respiratory viral infections and interstitial lung diseases are characterized by the large-scale expansion and migration of ectopic cells to alveoli, where they participate in a dysplastic form of remodeling, leading to long- term reduced lung function as well as increased mortality in cases of Idiopathic Pulmonary Fibrosis. The signals facilitating this dramatic proliferative/migratory event and whether these cells contribute to pulmonary fibrosis is unknown. This proposal will therefore investigate the role of NF-κB signaling in dysplastic remodeling and the pro-fibrotic function of these ectopic cells, thereby providing insight into the underlying mechanisms governing their migration and fibrotic pathology.